Conserved molecular features in cerebral small vessel disease

ABSTRACT
Small vessel disease (SVD) affects over 50% of Veterans over the age of 65 years. SVD increases the likelihood
of dementia by 2-fold and of stroke by 3-fold. Severe inherited SVD results in permanent disability and
dependency.
We seek to understand the most common inherited cause of SVD: CADASIL, a disorder caused by dominantly
acting mutations in NOTCH3. Hundreds of independent NOTCH3 mutations result in CADASIL, and virtually all
involve cysteine residues. As such, most in the field believe that conformational alterations driven by aberrant
disulfide bonding of NOTCH3 drives the disease process.
In this proposal, we seek to answer a fundamental question about mutant NOTCH3 in CADASIL: Is there a
signature alteration of the NOTCH3 protein shared by all CADASIL mutant proteins? The answer to this
question affects the design of therapies. If there is a signature alteration of NOTCH3 caused by all CADASIL
mutations, one therapy may be sufficient for all patients. However, if each mutation causes unique changes to
the protein, multiple small molecule therapies will likely need to be devised. This has practical implications for
planning of future clinical trials, since CADASIL is not a common condition.
We will test if a range of mutants share conformational alterations, protein binding properties, and interactions
with small molecules using reporter assays, proteome binding analysis, patient-based plasma proteomics, and
chemical genomic screens.
Successful completion of the aims will yield valuable deliverables: 1) data to support or refute that possibility that
different CADASIL mutations share a common structural change; 2) identification of candidate plasma
biomarkers for CADASIL; and 3) lead compounds that may be useful in treatment of SVD.

Public health relevance
NARRATIVE Small vessel disease (SVD) causes important conditions such as stroke and vascular dementia, but we still have limited understanding of its molecular pathogenesis. We use new approaches to identify the effects of mutations in NOTCH3 that lead to SVD, with the goal of understanding how these changes alter the protein, its partners, and drug interactions. Experiments are expected to lead to candidate biomarkers for inherited SVD.